Interdisciplinary training in pharmacological sciences

The Graduate Program in Molecular Pharmacology & Physiology is a small and very diverse
program with a strong set of courses and activities, as well as extensive mentoring mechanisms.
Leadership of the program is by a group of three accomplished MPIs with complementary
strengths and expertise that guarantee effective oversight of the program. The request is for 4
T32 slots per year; the total number of students in the program is 20. This training program in
"Interdisciplinary Training in Pharmacological Sciences" will replace our current NIGMS
pharmacology T32, ending in June of 2021. The training in our program focuses on fundamental
principles of pharmacology, rigor and reproducibility, and cutting-edge quantitative methods. Our
trainees participate in many activities that promote interaction, collaboration and professional
development. Here we propose a number of new initiatives in the curriculum, professional
development, program oversight and recruitment. A recent innovative initiative we are developing
in the program is the establishment of summer internships at Pfizer pharmaceutical company
labs; these internships will give our trainees the unique opportunity to experience first-hand the
scientific environment in a pharmaceutical company and make informed decisions for their future
careers. Our current admissions and recruitment practices have yielded a high percentage of
students from disadvantaged and underrepresented groups (in the last 5 years, 47%
underrepresented minorities plus 7% disabled), and there has been 100% retention of these
students in the program during the last 15 years (retention for the program in general is 95%).
The career outcomes of the students are excellent, with 52% of students staying in academia
(25% faculty, 27% currently postdocs) often at top institutions, about 25% as scientists in
pharmaceutical or biotechnology companies, and the remainder in a variety of science and
medicine- related careers. Thus, our program has been training a highly diverse group of students
who have become successful in different areas of science; the new initiatives proposed in our
T32 application will further enhance our unique program and improve the quality of the training.

Public health relevance
As there is continuing need to develop drugs to treat diseases, we are faced with training new scientists who understand the mechanism of these diseases, how to discover and characterize drug targets, how the drugs work and are processed by the body, and how to increase effectiveness and reduce adverse effects of the drugs. The collaboration of scientists from diverse backgrounds enhances creativity and innovation by bringing together a wide range of perspectives. Our program aims to 1) provide rigorous training that prepares PhD students to become leaders in the broad area of pharmacology and therapeutics; and 2) increase the diversity and quality of the national work force in this area.